Immuno-modulating Diffuse Midline Glioma by Epi-transcriptomic Reprogramming

Project Summary
Diffuse midline glioma (DMG) is the most aggressive primary brain tumor in children with a 5-year survival rate
of <1%. DMG characteristically has an "immunologically cold" tumor microenvironment (TME) leading to poor
clinical responses and resistance to immunotherapy. To overcome scarce lymphocyte infiltration and limited
immune checkpoint (IC) expression in cold TMEs, our team and others have established novel viral mimicry
activating therapies that leverage the accumulation of immunogenic dsRNAs and anti-viral innate immune
response to change the TME and sensitize tumors to immunotherapies. Traditionally, drugs that modulate the
epigenome have been used to activate the viral mimicry response in tumors. Unfortunately, these drugs have
lacked efficacy in DMG clinical trials amid dosing limitations secondary to systemic toxicities and poor neuropenetrance.
Thus, novel targets to activate viral mimicry and potentiate the immune response against DMG are
critically needed. We propose a paradigm shift to focus on targeting epi-transcriptomic (RNA modifications)
regulators, which promise to be more effective with less off-target effects in DMG. Via an unbiased screen, we
have found that the RNA editor ADAR is significantly upregulated in DMG. Interestingly, ADAR-mediated RNA
editing has been shown to help some cancer cells escape antitumor immune responses. In patient-derived DMG
cell lines, our preliminary results show that ADAR knockdown (KD) increases immunogenic RNA species,
activates an IFN response, reduces cell proliferation, and increases MHC-I and IC ligand levels on the tumor cell
surface. The objective of this proposal will be to determine the mechanism for the observed ADAR-dependency
in DMG cell lines, and to assess if this promising epitranscriptomic target activates viral mimicry to synergize
with immunotherapies against DMG in vivo. To determine modulators of ADAR-dependency, I will perform a
genome-wide CRISPR screen in DMG cells with a doxycycline-inducibleADAR KD background. This will inform
us what genes cause sensitization or resistance to ADAR-modulation in DMG. Next, I will assess if ADAR
knockdown synergistically enhances immune checkpoint inhibition (ICI, aPD-1) in a novel syngeneic orthotopic
immunocompetent murine DMG model. Utilizing a previously validated panel to characterize the DMG TME by
flow cytometry, we will assess the viral mimicry response by intracellular markers such as dsRNA levels and cell
surface markers such as CD45 and CD3 to determine immune cell infiltration, namely tumor-infiltrating
lymphocytes. This project seeks to understand the role of upregulated epitranscriptomic regulators in DMG from
an immunologic perspective and assess their efficacy as targets for viral mimicry therapy. The results of these
studies will open the doors to novel multi-modal regimens involving epitranscriptomic reprogramming and inform
potential clinical trials for immune modulation in DMG.

Public health relevance
Project Narrative Diffuse midline glioma (DMG) is the most aggressive primary brain tumor in children with a 5-year survival rate of less than 1 %. To overcome the limited response to immunotherapies in DMG's "immunologically cold" tumor microenvironment, our project aims to activate the immune system by targeting RNA modifications through the RNA editor ADAR to leverage the unique epigenetic dysregulalion of DMG against itself to promote tumor cell death. By doing so, we expect to enhance the effectiveness of immunotherapies and improve clinical outcomes for children with this devastating disease.